New biomarkers for early Alzheimer's diagnosis and tauopathy differentiation

Project Summary
Developing minimally invasive and low-cost AD and AD-related dementia (ADRD) tests with
high sensitivity and specificity is an urgent and unmet need for early AD diagnosis, differential
diagnosis with other tauopathies, monitoring disease severity, predicting disease courses, and
assessing effectiveness of drug treatment. In this project we will develop phosphorylated tau (p-
tau) new biomarkers for early AD diagnosis and for differentiation of AD from other tauopathies.
Through a systemic site-specific p-tau antibody screening, we have identified several new and
highly selective p-tau AD biomarkers from postmortem brain tissues. They are not only able to
differentiate AD from non-AD tauopathies, but also able to diagnose mild cognitive impairment
(MCI), an early disease stage of AD, from cognitively normal subjects with better diagnostic
performance than those of existing p-tau biomarkers, p-tau181 and p-tau217. We intend to
validate our newly discovered p-tau biomarkers in accessible biofluid plasma and cerebrospinal
fluid (CSF) by developing ultrasensitive single molecular array (Simoa) based tests for detection
and quantification. Two Specific Aims will be pursued. In Aim 1, we will develop novel biofluid p-
tau biomarkers for early AD diagnosis. In Aim 2, we will develop new p-tau biomarkers for
differentiating AD from other tauopathies. In both Aims, we will test our new biomarkers with
significant number of subjects, extend to premortem patient plasma and CSF samples, and
develop ultrasensitive Simoa biomarker tests. We anticipated our work has significant clinical
and translational values that may lead to AD and ADRD diagnostic tests with improved
sensitivity and specificity.

Public health relevance
Project Narrative Developing easy-to-use and low-cost assays with high sensitivity and specificity to detect early Alzheimer's disease (AD) and differentiate AD from other related dementias is urgent unmet need. We will develop novel biofluid misfolded tau protein-based molecular biomarkers for early AD diagnosis and for differentiating AD from other tauopathies. Our work may lead to significant clinical and translational advances in AD and ADRD medical diagnosis and related healthcare.